Apto-Ankle: Passive, Compliant Ankle with Enhanced Energy Storage and Return in Gait

PROJECT SUMMARY
The Apto-Ankle project will create a novel low-cost, lightweight, unpowered passive compliant ankle that
addresses the weaknesses of currently marketed hydraulic passive ankles by combining +/-10° of plantar and
dorsiflexion with a gait dependent toe lock to provide energy storage and return, all without use of
microprocessors or powered components.
Appropriate for DMERC K-2 and K-3 individuals with transtibial limb loss, it will help them more efficiently and
comfortably ambulate in their community environment, providing the documented benefits of passive compliant
ankles with a forefoot loading phase transition from energy dissipation in the ankle to energy storage in the
dynamic energy storage and return foot. This approach addresses the weaknesses of existing passive
compliant ankles without adding the power or complexity of microprocessor-controlled ankles. By mechanically
controlling dynamics based on parameters derived from normal ambulation and without additional cognitive
burden on users, this design provides a gait and environmentally appropriate transition during stance from
compliant, energy dissipation to dynamic energy storage and return.
The Apto-Ankle project has three primary aims: 1) design and construction of 3 prototype Apto-Ankles to test
adjustable components that determine gait dependent behaviors, both on the bench and on users, 2) bench
testing to assess ankle performance against design specifications and confirm safety and robustness prior to
clinical evaluation and 3) evaluate the proof-of-concept ankle by appropriately fitting it to users and evaluating
it in a gait lab. Primary assessment outcomes will include objective measurable gait parameters and
subjective clinical survey feedback from users. Successful design and implementation of the Apto-Ankle will
enable individuals with transtibial limb loss to more easily ambulate in their normal community environment,
increase stability, and increase amount of and comfort with ambulation in their typical activities and
surroundings. The commercial application of Apto-Ankle is a low-cost, K-2 and K-3, lightweight prosthetic ankle
that encourages ambulation, independence, and quality of life for transtibial prosthesis users.

Public health relevance
PROJECT NARRATIVE Existing passive ankles either severely limit the range of dorsiflexion to approximately 2° to provide energy storage and return in a dynamic foot or have unconstrained dorsiflexion and little to no energy storage and return, providing a sensation that users are “walking in sand”. The Apto-Ankle is a purely mechanical adaptive ankle prosthesis which allows for a broad range of dorsiflexion/plantarflexion for terrain adaptation while also maintaining energy storage and return in a dynamic foot by employing a novel dorsiflexion lock which operates based on fundamentals of gait mechanics. This design, suitable for K-2 and K-3 ambulators will improve comfort when walking on slopes, reduce metabolic cost, increase walking speed, increase overall ambulation, and increase stability during ambulation.